Multi-modal machine learning detection and tracking of traumatic brain injury neurodegeneration and its differentiation from Alzheimer's disease

ABSTRACT
The goal or our SBIR Phase II work is to develop a diagnostic tool using brain imaging and other biomarkers to identify
Chronic Traumatic Encephalopathy (CTE) and preceding stages in living individuals, and to differentiate these from
Alzheimer’s disease (AD) and other dementias. CTE is a devastating neurodegenerative disorder found in individuals who
have experienced repetitive head impact (RHI), causing symptoms of cognitive impairment that lead to dementia, and mood
and behavioral disturbances that may lead to violence or suicide. While CTE has been most publicized in retired NFL players
and “punch drunk” boxers, exposure to repetitive head impact occurs in soccer, hockey, military combat, domestic violence,
repeated falls in elderly, and other persons, with over 300,000,000 individuals at potential risk. Currently, although a clinical
diagnosis of Traumatic Encephalopathy Syndrome (TES) has been developed to suggest probable CTE, CTE can only be
diagnosed at autopsy and can be misdiagnosed during life as AD or other dementias. There are no treatments and no
means to detect earlier, progressive stages that could support the development of interventional treatments. Neuroimaging
biomarkers and their combination with fluid biomarkers have the potential to address the need for a CTE diagnostic by
detecting changes in brain connectivity, volume, function, and chemistries that comprise CTE’s progressive, cascade-like
deterioration. In our Phase I SBIR work, we applied machine learning methods to the volumetric (T1) and diffusion tensor
(DTI) magnetic resonance imaging (MRI) scans of fighters in the Cleveland Clinic Professional Fighters Brain Health Study
(PFBHS). We demonstrated a progressive pattern of effects and differentiation of persons with TES and likely CTE, patterns
of atrophy differentiating the effects of traumatic brain injury (TBI) from those in patients with AD related cognitive
impairment, and preliminary relationships to tau. Our Phase II Aims expand this work to include different populations with
RHI, within-subject longitudinal data analyses, and inclusion of functional imaging and fluid biomarkers toward achieving a
broadly applicable commercially available tool that can (a) detect and differentiate CTE from AD and (b) detect and stage
earlier progressive effects of TBI. We will use a uniquely comprehensive data set of multi-modality MRI, tau PET, clinical
endpoints, and fluid biomarkers from (a) 719 boxers, mixed martial artists, martial artists, and controls in the PFBHS set, of
whom 165 have at least 3 imaging visits; (b) 240 former professional and college football players and controls (DIAGNOSE-
CTE); (c) 219 collegiate contact sports athletes and controls (CARE); (d) 600 Vietnam veterans with TBI and/or Post
Traumatic Stress Disorder and controls (ADNI-DOD); and (e) individuals from our reference set of over 30,000 MRI and
PET scans from individuals representing a spectrum of cognitively normal and cognitively impaired states associated with
AD and other dementias. Building on our success from Phase I, we will develop expanded Canonical Variate and deep
learning classifiers using imaging and fluid biomarkers that can be applied in the clinic to evaluate persons with a history of
RHI. Input regarding clinical utility and interpretability from our expert Advisors will be used to guide report design. These
Aims provide the foundation for commercial products and services supporting CTE differential diagnosis and treatment
development.

Public health relevance
NARRATIVE Chronic Traumatic Encephalopathy (CTE) is a progressive, devastating condition associated with repeated head impact that causes brain deterioration leading to problems with mood, thinking, and behavior, but which cannot be definitively diagnosed until autopsy. There is a tremendous need for a diagnostic tool that can be used in the clinic to assess persons with a history of RHI, which includes an at-risk population of more than 300,000,000 worldwide involved in contact sports, military combat, and domestic violence. Using artificial intelligence (machine learning) and an extensive collection of brain images and blood measures from boxers, football players, and other settings, we plan to develop a diagnostic tool to enable diagnosis in the clinic and treatment development for CTE.